URTICARIA PIGMENTOSA

To evaluate retrospective data indicated in selected patients diagnosed with Urticaria Pigmentosa and to develop prognostic criteria for UP particularly with respect to the potential for progression to more chronic disease.